Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core's purpose is to coordinate and facilitate activities across all Research Projects and the
Community Engagement Core (CEC) to ensure synergy across the North Carolina Center for Coastal Algae,
People, and Environment (NC C-CAPE). The Administrative Core's Specific Aims include: 1) Create and
coordinate a centralized hub for NC C-CAPE activities; 2) Provide systems and processes that foster
transdisciplinary interactions between NC C-CAPE research projects and cores; and 3) Implement
mechanisms that facilitate translation of NC C-CAPE discoveries and broaden the impact of Center
findings. The Administrative Core will be led by an Internal Steering Committee consisting of the Center Director,
Co-Director, Project 3 Leader, and CEC Director. This collaborative leadership approach reflects the recognized
need for multiple areas of expertise – oceanography, environmental health, climate modeling, and community
engagement – to be engaged in decision-making that impacts the Center as a whole. A full-time Business
Manager, with coordinated effort across both the Administrative Core and CEC, will manage logistics of Center
activities, track Center-wide metrics in support of the program evaluation plan, and promote communication
across the Center, NC State leadership, and the NC C-CAPE external stakeholders. The Administrative Core
will foster interdisciplinary approaches by striking a balance between efforts internally, such as coordinating a
research seminar series, and externally, through activities such as convening the External Advisory Committee
and collaborating with other Oceans and Human Health Centers and projects with shared interests. Driven by
the CEC's leadership, NC C-CAPE has adopted a data justice framework that shapes our approach to
Resource Sharing. The Administrative Core will ensure that this framework, including a commitment to making
data both publicly available and accessible, will be implemented across all Research Projects. Importantly, this
framing of data justice will also inform the Center's efforts around developing early stage investigators. The
Administrative Core will help facilitate co-mentoring across the Research Projects and the Community
Engagement Core to give students and other early stage researchers opportunities to understand how their
scientific areas can collaborate with other disciplines and stakeholders around the topic of sharing data. By
setting an organizational culture that fosters collaborations across disciplinary boundaries, the Administrative
Core will assist the Center in advancing our understanding of how climate, algal blooms, ocean, animal and
human health are connected.